Second-Generation Novel Liver Stage Active Antimalarials

PROJECT SUMMARY/ABSTRACT
The global impact of malaria remains staggering despite extensive efforts to eradicate the disease. We
have developed a novel antimalarial acridone chemotype with dual stage efficacy against both liver stage and
blood stage malaria, as well as single-dose cure ability and potential to prevent relapsing infection. The ability
to combat multiple stages of the infection represents a powerful tool, and one ideally suited to achieve the
broadest possible benefit as the malaria eradication effort proceeds. A rigorous optimization process has
produced a series of second-generation acridones with significant improvements in efficacy, metabolic stability,
pharmacokinetics, and safety profiles. Our overarching goal is to develop a novel antimalarial that is safe in
individuals with G6PD deficiency, and in the most vulnerable populations – pregnant women and children, thus
supporting world-wide elimination of the disease. The specific goal of this project is to conduct lead
optimization studies to produce second-generation candidates for full preclinical evaluation that retain the
broad-spectrum features and demonstrate enhanced efficacy, safety, solubility, and metabolic/pharmacokinetic
profiles; to investigate the propensity for drug resistance to selected acridone candidates and identify the
molecular target(s) through whole genome sequencing and analysis; and to explore mode(s) of action for these
liver stage active antimalarial acridones using functional assays and bioanalytical approaches.

Public health relevance
PROJECT NARRATIVE Malaria remains one of the deadliest diseases in the world today and accounts for over 200 million clinical cases worldwide each year along with roughly half a million deaths, mostly children under the age of five and pregnant women. With increasing drug resistance and the absence of a clinically available vaccine, there is an urgent need and continuous search for novel, affordable, and safe drugs for prevention and treatment of malaria. We have developed a novel antimalarial acridone chemotype that is potent against both blood stage and liver stage malaria parasites, with single-dose cure ability and potential to prevent relapsing infection, that warrant further preclinical development.